Capturing, quantifying, and understanding combinatorial effects in small molecule signaling

Project Summary/Abstract
Chemical landscapes in biology consist of thousands to millions of different small molecules, such that cells
and organisms always experience any single small molecule in the context of other molecules. Indeed,
biological processes from cell fate decisions to regulation of central metabolism are driven by combined action
of multiple small molecules. Insight into such combinatorial effects, however, is largely based on anecdotal
evidence; as yet, there exists no coherent framework to capture and quantify combinatorial effects in small
molecule signaling. This gap limits the ability of scientists to study signaling in the complex chemical
landscapes found in biology, to predict biological activities of small molecules, and to manipulate small
molecule signaling in the context of disease.
This work will develop a conceptual, experimental, and analytical framework to capture and quantify
combinatorial effects of different molecules, or “chemical epistasis”. As a starting point, this work will focus on
signaling in the context of communication between the human microbiome and the human host, which provides
an ideal testbed. Working in this context, the first goal is to develop experimental and analytical approaches to
capture chemical epistasis and to use these approaches to measure empirically how pervasive chemical
epistasis is in pairwise combinations of small molecules from the human microbiome. From there, this work will
continue in three broad directions: 1) a broader exploration of the scope and manifestations of chemical
epistasis including in combinations of three or more small molecules; 2) a dissection of mechanisms underlying
chemical epistasis, using a combination of systematic CRISPR screens and focused approaches; and 3)
exploration of the physiological consequences of epistasis, harnessing defined microbiome communities to
independently control the concentrations of multiple small molecules in vivo. This work will be transformative
for efforts to establish causal links in host-microbiome interactions and to predict and manipulate outcomes of
host-microbiome communication, for example to alleviate microbiome-associated diseases. More broadly,
complex chemical landscapes are a central feature of biology, and this work will lay the groundwork to
understand signaling in these landscapes.

Public health relevance
Project Narrative Chemical landscapes in biology are composed of thousands to millions of different small molecules, which means that a cell or organism is always exposed to many different small molecules at the same time. The overall goal of this project is to understand how biological outcomes may be driven by combinatorial effects of multiple small molecules, with an initial focus on such effects in the context of host-microbiome communication. This work may allow us to predict and manipulate effects of the microbiome on the human host and more broadly will establish general models to describe signaling in complex chemical landscapes, which are ubiquitous in biology.